A Phase II Controlled Trial of Allogeneic Mesenchymal Stem Cells for the Treatment of Refractory Lupus

PROJECT SUMMARY/ABSTRACT
Determining the clinical effectiveness of mesenchymal stem cells (MSCs) and their mechanism of action in
treating refractory lupus is of significant importance. We and others have reported reproducible improvement in
murine models of lupus following allogeneic MSC infusions from healthy mice or humans. Infusion of MSCs,
derived from bone marrow or umbilical cords, in more than 100 treatment-refractory lupus patients has resulted
in positive clinical benefit in 65-75% of those treated. However, a placebo-controlled trial of MSCs in lupus has
not been performed to show definitively that MSCs are more effective than standard of care. One clear result
from multiple trials of MSCs to date is that they can be given safely with almost no serious adverse events. The
preclinical data, the uncontrolled trials and the safety profile create a mandate for a controlled trial to test the
efficacy of MSCs as a therapeutic for lupus. Critical to this trial are mechanistic studies to define how MSCs
impact disease. Prior studies in lupus and rheumatoid arthritis reported increased circulating Treg cells,
decreased Th17 cells, decreased TFH cells and fewer activated B and plasma cells in patients after MSC
infusion. The mechanism by which these cellular effects occur is unknown. We have found that lupus patients
have decreased circulating levels of glycoprotein A repetitions predominant (GARP)/TGF complexes. MSCs
express GARP, and GARP is a major determinant of TGF bioactivity and also has important enhancing
effects on Treg number and function. We hypothesize that allogeneic MSC infusion, plus standard of care, will
prove significantly more effective in treating lupus patients with active disease than standard of care alone. We
further hypothesize that effects of MSCs in lupus occur via modulation of regulatory and pathogenic T and B
cells through upregulation of GARP expression, resulting in enhanced TGF bioactivity and increased Treg
numbers and activity. To test these hypotheses, our specific aims are to:
1. Determine the safety and efficacy of mesenchymal stem cell therapy in a two-dose escalation double-
blind placebo-controlled multi-center trial as a treatment for lupus patients with moderate to severe
disease activity unresponsive to standard of care therapy compared to ongoing standard of care.
2. Define mechanistically how MSCs modulate regulatory and pathogenic T and B cells in lupus patients
and the role of GARP-mediated TFG bioactivity in this process.
The proposed trial will be performed in six academic centers that are all skilled, successful and experienced in
performing lupus trials. If we confirm that MSC therapy is as effective as reported, then MSC infusions may
become an alternative therapy for lupus. The detailed mechanistic analysis will provide novel insight into the
complex cellular matrix in lupus and the impact MSCs have on these cellular interactions. There is a defined
FDA pathway for licensing cellular therapies allowing this therapy, if effective, to be translated to the clinic.

Public health relevance
PROJECT NARRATIVE Mesenchymal stem cells may be derived from a variety of sources including bone marrow, fat tissue, dental tissue and umbilical cords. They have proven ability to block inflammatory responses and can be given safely to unrelated individuals. In preliminary studies, they show promise as a novel safe effective therapy for treating lupus, but no controlled trials have been done to prove they are indeed effective. Successful completion of the proposed trial and corollary mechanistic studies will provide valuable insight into the efficacy of mesenchymal stem cell therapy in treating lupus as well as the immune effects of mesenchymal stem cells in humans and how these effects correlate with clinical benefit.